A Mixed Methods Investigation of Self-Care of Chronic Illness in Community-Dwelling Older Adults with Hearing Loss

Project Summary
The goal of this individual National Research Service Award (NRSA) application is to provide the
applicant with research training to become an independent investigator addressing disability health equity for
older adults with hearing loss (HL) by focusing on the role of hearing loss (HL) in health maintenance practices
such as self-care of chronic illness. To achieve this goal, training will occur in a resource rich environment with
support from a multidisciplinary mentorship team with expertise in HL, nursing, aging, disability health equity,
health promotion, chronic illness, biostatistics, mixed methods, and qualitative research. The applicant
proposes a training plan that includes coursework, practical training, seminars, and engagement in ongoing
research. Specific training goals of this award include: 1) Gain a foundational understanding of the principles of
health equity research, focusing on disability health equity, 2) Continue developing the methodological and
analytical qualitative, quantitative, and mixed methods skills required to conduct rigorous mixed methods
research, 3) Develop theoretical and conceptual knowledge in the science of HL, aging, chronic illness, and
self-care to support empirical investigation and intervention development, and 4) Acquire professional
development skills to support a career as an independent investigator at a research-intensive university.
The research proposed for this NRSA addresses the role of HL in self-care of chronic illness. Millions of
older adults have clinically meaningful HL and a chronic illness. Self-care is a cornerstone of health promotion
and management chronic illness. Yet, the impact of HL on self-care of chronic illness is not well understood.
Using an integrated biopsychosocial model of disability and self-care as the guiding framework, the applicant
will examine the role of HL in self-care of chronic illness. This study proposes the following aims: 1) Describe
self-care behaviors in older adults with unaided HL and compare self-care behaviors by HL severity, 2) Explore
the experience of caring for chronic illness while having unaided HL, and how HL impacts self-care, and 3)
Describe differences in the experiences of self-care of chronic illness by self-care behavior scores and HL
severity. This mixed methods study will use a parallel-convergent design to enroll a single sample of
community-dwelling hospitalized older adults with a chronic illness and unaided HL. The proposed study aligns
with the priorities of the National Institute of Nursing Research by advancing health equity for people with
disabilities, through addressing health promotion and disease prevention in older adults with HL. Having a
greater understanding of how HL influences self-care behaviors will support the development of interventions
enabling older adults with HL to maximize health through self-care.

Public health relevance
Project Narrative Millions of older adults have hearing loss and a chronic illness, yet the role of hearing loss in health promotion and disease prevention practices is poorly understood. This mixed methods study examines how hearing loss influences self-care of chronic illness in older adults. Findings are anticipated to inform the development of clinical interventions to improve chronic illness care delivery, enable self-care participation and improve health outcomes for the millions of older adults with hearing loss and a chronic illness.